Crucial spinal circuit changes that mediate locomotion benefits of combined biological/bionic/rehabilitation therapies after spinal cord injury.

Abstract
Our project represents a new collaboration of two laboratories with differing but complementary skills, with the
goal of understanding plasticity of specific spinal circuits and the effects of epidural stimulation on these. The
project is built on new observations and paradigms developed by both our laboratories. Although we
understand increasingly more about both (a) spinal circuits at the level of molecular genetics identified
developmental interneuron classes and (b) spinal plasticity in the context of spinal cord injury (SCI), these two
types of information are only rarely integrated experimentally to fully leverage the power of their combination.
We will use a novel paradigm which explores the combination of biological/viral, bionic and rehabilitation
therapies in complete SCI in both the rat and the mouse in order to obtain the power of both approaches in
analyzing spinal plasticity and pathology after SCI. In the rat model in this paradigm we already have new data
showing that the combination of rehabilitation and virally derived BDNF treatment after complete SCI leads to
significant gains in function as a result of this combination treatment. However, in 40% of the treated rats, after
the initial high gains achieved, it was observed that a hyperreflexia developed, causing a large collapse in
function. In contrast, it was observed that in rats which also receive epidural stimulation (ES) of lumbosacral
spinal cord during treatment (in addition to the viral driven BDNF and rehabilitative treatments) no rats showed
any such hyperreflexia. This project seeks to use this paradigm to understand plasticity of spinal circuits that
support function, create hyperreflexia and collapse, and that prevent such collapse with ES. We do not yet
know if there exist specific time windows for the ES efficacy in preventing collapse. The ES in some way steers
the course of plasticity away from pathology in the model when applied in a timely way. Our overall Aims are to
characterize the best timing of ES and to understand in detail many of the changes that result. We seek to
determine if specific genetically identified circuits show plasticity, and are targets of ES, and how these circuits
contribute and alter in order to support walking functions. We also seek to understand what goes awry to cause
collapse of function in some animals without ES treatment. Our planned work is important and impactful
because it will shed new light on circuit changes and function after SCI. It will test how identified interneuron
populations and functional circuits in the spinal cord are altered. It will deepen and broaden our understanding
of the actions of epidural stimulation in promoting and shaping spinal plasticity supporting walking, and identify
the therapeutic targets, windows of action, and interactions of epidural stimulation with other therapies. ES is
becoming a promising and broadly applicable therapy for SCI conditions, but our understanding of fundamental
mechanisms of action and interaction with other therapies remains limited. This project begins to address this
gap using precise physiological and genetic methods.

Public health relevance
Narrative The planned work is important and impactful because it will shed new light on how the spinal cord changes and can be steered to improvement after spinal cord injury (SCI). Epidural stimulation is a promising and broadly applicable therapy for many SCI conditions, but our understanding of fundamental mechanisms of action and interaction with other therapies remains limited. The project will deepen and broaden our understanding of the actions of epidural stimulation in promoting and shaping specific spinal circuits and their plasticity to support walking, and it will identify the therapeutic targets, windows of action, and interactions of epidural stimulation with other therapies.